Visual Function Testing Core

Project Summary
A Visual Function Testing Core will provide expertise, instrumentation, and training on technologies used to
quantify visual performance in mice and other model systems. ERG, VEP and optometry analysis are
supported. This core also includes technical support for the fabrication, diagnosis and repair of electronic
equipment.
Provision of these support services and resources will greatly enhance the research capabilities of
investigators at Washington University and will facilitate collaboration among new and established vision
scientists.